Integrative Health Sciences Facility Core

Integrative Health Sciences Facility Core (IHSFC) ABSTRACT

The Texas A&M Center for Environmental Health Research (TiCER) is focused on “Enhancing Public
Health by Identifying, Understanding and Reducing Adverse Environmental Health Risks.” The IHSFC will be
the major driver to fulfill the mission of the Center: to identify and address environmental health concerns
through multidisciplinary collaborations among Center members and other stakeholders. IHSFC fulfills the
mandate for the Environmental Health Sciences Core Centers to provide “facilities and resources to accelerate
research along the spectrum from basic mechanistic and toxicological science to population and public health
and dissemination.” The goal of IHSFC is to facilitate bi-­directional translational studies ranging from
research in the community-­based human cohorts, to population-­based experimental studies in mice
and human cells, to microphysiological in vitro systems. This goal will be accomplished by integrating the
Center’s translational research into causes and mechanisms of environmental health risks among three major
areas of inquiry: (i) human community-­based translational studies and databases, (ii) mouse population-­based
and transgenic models, and (iii) novel in vitro models. The IHSFC will be led by Dr. Ivan Rusyn, an expert in all
three areas of inquiry. The human translational studies area, led by Dr. Natalie Johnson, will focus on
facilitating community oriented research projects, enabling access to health and environmental information-­
containing databases, and consulting on IRB compliance. The mouse translational studies area, led by Dr.
Ben Morpurgo, will focus on study designs and access to Collaborative Cross and RIX mouse populations,
transgenic/knockout services (including CRISPR/Cas9), and IACUC compliance. The in vitro translational
studies area, led by Dr. Ivan Rusyn, will focus on the use of novel microphysiological (human and mouse
organoids, stem cells, and tissue chips), and population-­based in vitro tools, as well as advising on biosafety
compliance. The IHSFC will enable center members’ integrative research through dedicated staff in each area
and a voucher-­based model. The Core will provide up to $100,000 per year (½ from NIEHS and ½ from Texas
A&M) to facilitate Center members’ access to and use of translational resources. The IHSFC function will
include (i) close integration with the Pilot Projects Program, the Community Engagement Core, and research
facility cores through monthly meetings to identify and promote integrative and translational projects, and (ii)
key personnel and staff outreach to Center members to encourage and initiate projects. The IHSFC will work
closely with the Administrative Core to track the Core’s operation and funding allocations and with the Pilot
Projects Core to identify projects that may benefit from IHSFC expertise, equipment and resources. The IHSFC
leaders have an established record of accomplishment in collaborative research among themselves and with
many Center members and IHSFC is well positioned to enhance translational research bi-­directionally along
the spectrum from basic to community-­based research to address public health challenges.